Decoupling Mechanical and Inflammatory Stimuli in Discogenic Low Back Pain

PROJECT SUMMARY
Chronic low back pain (LBP) is one of the major contributors to musculoskeletal pain, disability, and lost workdays
in the United States. LBP is highly correlated with degeneration of the intervertebral disc. Discogenic pain,
specifically, is the leading cause of LBP. Patients with chronic discogenic LBP often exhibit aberrant sensory
nerve growth deep within the disc. Once nerves are present in the degenerate disc they can be subjected to a
complex milieu of pro-inflammatory mediators and dynamic mechanical loads causing stimulation and therefore
pain. Binding of pro-inflammatory mediators to receptors on nociceptors results in lowered stimulation thresholds
of ion channels responsible for action potential generation. Whereas mechanical loading of the disc can cause
direct stimulation of mechanosensitive ion channels resulting in pain sensation. Previous work has explored the
use of local delivery of an anti-inflammatory to the disc, however, incomplete pain resolution was observed. No
work has examined targeting mechanoreceptors in the disc to alleviate chronic discogenic LBP. Further, no
studies have yet been able to parse out which the role of nerve presence, inflammation, or mechanical loading
is the major contributor to emergent pain. This question remains unanswered due to a lack of animal models that
accurately mimic human presentation of chronic discogenic LBP.
Taken together, these data support our overarching hypothesis that the presence of new nociceptors in the disc
combined with inflammation and/or mechanical loading leads to chronic discogenic LBP, and targeted peripheral
therapies may alleviate LBP. To test this hypothesis, we have developed an animal model of chronic discogenic
LBP that exhibits a robust behavioral pain phenotype and nerve infiltration deep within the disc. By using
innovative rodent models and targeted blockade of nerve growth, inflammatory mediators or mechanical sensing
we will probe the roles of nerve presence, inflammation, and loading in LBP. We will then use this information to
develop novel approaches to alleviate chronic discogenic LBP. Further, findings will be validated in aged animals
which are more representative of a human LBP patient. The proposed work will use novel approaches using
targeted neuro-inhibition, anti-inflammatories and mechanoreceptor antagonism to decouple the role of nerve
presence, inflammation, and mechanical loading in LBP. The outcomes from this work include and better
understanding of the specific mechanisms of LBP, laying the foundation to develop peripherally targeted pain for
an intractable and widespread condition that is increasing in prevalence.

Public health relevance
PROJECT NARRATIVE Low back pain will affect the majority of the population at some point in their lifetime, and many of these patients’ pain may be caused by nerve growth, inflammation, and altered mechanical loading. Despite this knowledge, current treatments do not target these features, because their relative contribution to the pain is unknown. Our work seeks to use a novel rodent model of chronic low back pain to investigate the role of nerve presence, inflammation, and mechanical stimulation on pain generation.